Biocreative Conference Grant

DESCRIPTION (provided by applicant): The goal of this proposal is to provide a venue for the evaluation of biomedical text mining tools via the shared task paradigm, particularly tools with relevance to problems in biocuration. Biocurators will help define use cases and desired functionalities; stakeholders will come to agreement on task definitions, data sets, and evaluation metrics; text mining teams will then work on these consensus tasks and come together to share their results and gain further feedback from biocurators.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project consists of the evaluation of biomedical text mining tools, particularly ones applied to projects in biocuration. The results of biocuration are extensively used in modern medical practice, particularly personalized medicine, so the work of the grant has the potential to have a substantial impact on the cutting edge of human healthcare.